Fatty Acid Oxidation in Regulation of Drug Hepatotoxicity

SUMMARY
The acetaminophen (APAP) overdose or abuse that causes severe liver injury and failure remains a great threat
to the general population and veterans. A better mechanistic understanding of APAP-induced liver injury (AILI)
and liver regeneration after drug insult will help advance therapeutic development to improve outcomes. Although
dysregulated fatty acid oxidation (FAO) has been implicated in multiple liver diseases, its exact role in drug
hepatotoxicity including AILI remains elusive. We discovered that inhibition of FAO or its rate-limiting enzyme
carnitine palmitoyltransferase 1A (CPT1A) exacerbated AILI and also impaired liver recovery whereas enhancing
FAO provides significant hepatoprotection. Our findings suggest that metabolic activation of FAO serves as a
crucial regulator governing liver homeostasis in APAP hepatoxicity. Intriguingly, this CPT1A-FAO machinery
actively operates with distinct functions in both hepatocytes and liver-resident macrophages. The objective of
this project is to interrogate the CPT1A-FAO pathway in regulation of the highly integrated molecular and cellular
processes in liver injury as well as regeneration, a critical determinant of the final outcome. We will establish an
under-appreciated role of hepatocyte autonomous FAO for counteracting APAP-triggered cytotoxic stress and
especially for driving hepatocellular renewal during tissue recovery. In addition, using models with CPT1A
selectively deleted in macrophages and other tools, we will determine a previously unrecognized role of FAO in
functionally skewing these myeloid cells to attenuate abnormal hepatic inflammation and accelerate the tissue
regenerative process. Currently, N-acetylcysteine, which has limited benefits, is the only treatment option for
APAP overdose. In this application, we will also evaluate a novel AMP-activated protein kinase agonist for
reprogramming hepatic FAO activity to mitigate APAP hepatoxicity while concurrently stimulating liver
regeneration. These comprehensive studies will advance our understanding of a new mechanism that defines
the pathogenesis of AILI and help identify novel targets for drug discovery. Our research is highly significant and
clinically relevant because successful development of the innovative FAO-modifying treatment to manage APAP
overdose can broaden therapeutic benefits to the general public and veterans.

Public health relevance
NARRATIVE Acetaminophen (APAP), a common, over-the-counter household drug used alone or in combination with many other medications as an antipyretic and analgesic, has become the leading cause of drug overdose and acute liver failure. The amount of chronic pain and mental-health problems in veterans has led to the combination of high prescription levels and greater likelihood of APAP overdoses. Our research is focused on a previously unstudied metabolic pathway involved in hepatoprotection and liver regeneration, which may lead to novel treatment modalities for improved disease management.